Scalable Molecular Pipelines for FAIR and Reusable BICAN Molecular Data

PROJECT SUMMARY
This project will create scalable resources that will be critical to the development of BRAIN Initiative Cell Atlas
Network (BICAN) consortium brain atlases. This team will focus on the development of common molecular
data processing pipelines that are cloud-native and FAIR. Starting with an already established portfolio of
BICCN pipelines and community relationships developed in previous funding, this portfolio will be updated and
extended in collaboration with the BICAN community. Leveraging and improving existing integration between
the BICCN molecular (NeMO) archive and cloud-computing environment (Terra), this team will process data
sets, prioritized by the BICAN community and in support of joint analysis for atlas building. These pipelines will
produce data with a comprehensive panel of metrics that our team will leverage to perform quality control and
assure rigor in data processing and use. This team will work with analysis groups to confirm outputs of the
pipelines are compatible with downstream analysis and are extended to incorporate critical downstream steps
as they mature and are agreed upon by the BICAN community. The cloud computing environment used by this
team will be open and available to the BICAN community and supported by a helpdesk, documentation,
forums, and an annual workshop. As this infrastructure spans institutes, Terra is currently enabling BICCN
working groups to share cloud resources and jointly analyze data in a common scalable space; this will
continue to be true in the BICAN community. To enable visualizing, sharing and publishing of data, this team
brings cloud programming environments (Terra), specialized scalable resources (Cirrocumulus, Pegasus), and
publication portals (NeMO Analytics, and the Single Cell Portal) to be leveraged in consortium activities. These
common resources will be critical to enable the BICAN community to come together and perform analysis that
scales to the needs of BICAN atlas building efforts.

Public health relevance
PROJECT NARRATIVE The Scalable Molecular Pipelines for FAIR and Reusable BICAN Molecular Data CUBIE will develop common FAIR data processing pipelines, quality control measures, and process BICAN data in an open scalable environment to support the building of BRAIN Initiative Cell Atlas Network consortium brain atlases.